Development and Application of Chemical Biology Approaches for Understanding Protein Arginylation

Project summary
Posttranslational arginylation on proteins installed by arginyltransferase ATE1 is a critical modification for
cardiovascular and heart development. The absence of this modification in ATE1 knockout mice was
embryonically lethal with various signs of cardiovascular defects, emphasizing the importance of arginylation in
physiological processes. Existing methods have proposed plausible arginylation sites on a handful of proteins,
most of which have not been further validated or functionally investigated. Therefore, protein arginylation remains
a vastly understudied field. It is still largely unclear how many proteins are arginylation substrates in cardiac
tissue/cell proteomes, and what the effects of arginylation are on cardiovascular development? In this proposal,
we will first establish a chemical proteomics platform for enriching the arginylation sites to facilitate the discovery
of this challenging PTM. We will apply this technology to cardiac cells and clinical heart tissues to
comprehensively profile the arginylation sites hidden in cardiovascular networks. In addition, our preliminary data
discover that another cardiovascular-related molecule, homoarginine, is a proteinogenic amino acid, we thus will
use isotopic homoarginine to unbiasedly discover the occurrence and distribution of the “homoarginylome” and
homoarginine-associated metabolites in cardiovascular samples as well. These investigations will provide
insights into the biological effects of homoarginine as an amino acid building block and a metabolite. We next
focus on the elucidation of protein arginylation function in selected systems. A combination of mass spectrometry,
biochemistry, and next-generation sequencing techniques will be used to study the conformational alterations of
nucleosome after arginylation of histones to understand how epigenetic mechanisms can be regulated by
arginylation during cardiomyoblast differentiation. By controlling the calreticulin arginylation levels, we will also
study the impacts of arginylation on cardiac differentiation and development using stem cell and cardiology
techniques. To further explore the therapeutic potential of protein arginylation, we aim to establish the
arginylation targeting chimera (ArgTAC) technology for targeted PCSK9 arginylation and degradation.
Successful degradation of PCSK9 by this arginylation system will potentially provide a novel therapeutic strategy
in lowering LDL particles leading to improved cardiovascular conditions. Since protein degradation is the only
known mechanism to remove protein arginylation, we will further explore the novel possibility that enzymes exist
for de-arginylation of proteins (reversing arginylation). Towards this, we will apply CRISPR whole genome
screening to identify putative de-arginylation enzymes before validation using enzymatic assays to characterize
their de-arginylation activity. The proposed studies will unveil the prevalence and noncanonical biological roles
of this essential PTM, and the novel technologies from this proposal will greatly benefit the research fields of
protein arginylation, epigenetics, and cardiovascular disease.

Public health relevance
Project Narrative While functional studies have identified arginylation as a regulatory post-translational modification on a few proteins, modification sites and altered functions resulting from arginylation are largely unknown. This proposal aims to unbiasedly unveil the arginylation sites in cardiovascular proteomes, elucidate the epigenetic and cardiac development mechanisms of arginylation, explore the therapeutic potential of arginylation for targeted protein degradation, and discover de-arginylation enzymes. These studies and technologies will provide a fundamental basis to uncover the noncanonical functions of protein arginylation in cardiovascular development and disease.